Effects of 12-weeks of High-intensity Resistance Aerobic Circuit Exercise Training on Epigenetic Aging and Inflammation in Older HIV-infected Veterans

The Veterans Health Administration (VHA) is the largest U.S. HIV health provider with 64% of these
Veterans 50+ years of age. HIV infection in the setting of antiretroviral therapy represents a chronic disease
with an advanced aging phenotype manifested as increased cardiovascular disease, sarcopenia, and frailty,
primarily driven by systemic inflammation. We found a 42% reduction in VO2peak in older HIV+ adults that
significantly improved with high-intensity aerobic (AEX) and resistance training (RT). Yet, durable strategies for
high-intensity exercise in older adults remain a challenge and limited data are available in older HIV+ adults.
There is an urgent need to address these knowledge gaps in order to prevent widespread disability in HIV+
Veterans. Our objective is to provide a high-intensity exercise program for older Veterans that can be widely
disseminated and attenuates processes underlying aging. Epigenetic changes with increased age encapsulate
the putative effects of biological aging and lifestyle factors. DNA methylation (DNAm) patterns are frequently
modified in genes encoding pro-inflammatory cytokines, but can be reversed with exercise training. DNA
methylation age (DNAm Age) is an epigenetic biomarker that is expressed in years and provides a concrete
benchmark of advanced aging. We found that HIV+ adults have DNAm Age 11 years greater than age-
matched adults without HIV. Further, in adults without HIV, increased DNAm Age is associated with physical
inactivity, weakness and frailty. Our preliminary data in the Veterans Aging Cohort Study (VACS) show that
DNAm Age correlates with the VACS Index, a measure of frailty in HIV+ adults. However, the impact of
exercise training on DNAm Age has yet to be determined in any patient population. We propose to adapt our
center-based high-intensity AEX+RT intervention in older HIV+ Veterans into a video telehealth (VTEL)
delivered functional (no stationary equipment) exercise program that leverages epigenetic outcomes to
demonstrate anti-aging effects of exercise. The overarching hypothesis is that VTEL high-intensity
functional circuit exercise in older HIV+ Veterans will improve the advanced aging phenotype and
attenuate DNAm epigenetic processes underlying aging. Our experimental approach includes a 12-week
VTEL exercise intervention in 80 older HIV+ Veterans who are randomized to exercise or standard of care
sedentary control groups. AIM 1 will determine the effect of VTEL exercise on VO2peak, sarcopenia, and frailty
as phenotypic outcomes of advanced aging in HIV. AIM 2 will investigate the effect of VTEL exercise on DNAm
Age as a biomarker of advanced aging. AIM 3 will determine the effect of VTEL exercise on DNA methylation
of specific genes encoding specific pro-inflammatory cytokines in leukocytes. This approach will advance our
understanding of effective and feasible exercise strategies to prevent and minimize disability in patient
populations with advanced aging. Findings will provide an innovative approach to functional exercise in all
older adults. DNAm Age could be used as a personalized benchmark for an individual’s benefit from exercise
to promote sustainable behavior change. Findings will also provide epigenetic risk profiles that can be used to
generate a personalized exercise prescription, an important next step in the next decade of precision medicine.
The proposal leverages our exercise training experience in HIV and VTEL, availability of 3,000 HIV+ Veterans
at Atlanta and Baltimore VAMCs, and the VHA VTEL infrastructure. The capacity to disseminate VTEL
exercise with minimal cost using existing infrastructure will facilitate large-scale dissemination and national
impact. Deliverables include improved clinical outcomes and substantial cost savings from reduced
hospitalization and institutionalization rates.

Public health relevance
Most Veterans living with HIV are 50 years of age or older and can expect to live more than 20 years longer with HIV medication. However, despite this success, Veterans living with HIV are more likely to have age-related diseases and loss of fitness and muscle that place them at increased risk for disability. This is a major priority for the VHA, the largest provider of HIV care in the United States. The goal of this study is to test a circuit exercise program in Veterans living with HIV that is designed to slowdown the aging process. The exercise program will be widely available by Video Teleconferencing (VTEL) and does not require stationary exercise equipment, making it widely accessible. The research will help us reach our goal for Veterans to preserve their quality of life and ability to function independently. Novel findings will strengthen our strategies to maintain life-long fitness through a personalized exercise prescription.